Functional and Mechanistic Analysis of Mesenchymal Stem Cell Secretome to Ameliorate Ischemic Damage of Rodent Hearts in situ and Human Myocardium-on-a-Chip

Use of heart transplantation is limited by severe shortage in donor organ supply, resulting in death of many
heart transplantation candidates before a suitable donor heart becomes available.1, 2 In addition to the scarcity
of total donor hearts, national transplant data collected by the Association of Organ Procurement Organizations
indicates that nationwide approximately 70% of cardiac allografts were rejected for transplantation during
2009–2011. The majority of these hearts were discarded due to stringent acceptance criteria, one of which is
the limited acceptable time between procurement and transplantation. This time correlates with progression of
myocardial ischemia/reperfusion (I/R) injury, and constrains the acceptable geographic distance between the
sites of donor heart explantation and transplantation. Overall, there is an urgent need to develop effective
approaches to increase transplantable grafts by improving the numbers of organs which will fulfill acceptance
criteria. Amelioration of I/R injury despite prolonged transport times and in organs felt to be potentially marginal
will improve preservation of graft function, thus expanding the donor pool and increasing access.
Human adipose-derived stem/stromal cells (hASC) represent a uniquely practical subtype of MSC, due to
their abundance, the simplicity of isolation from adipose tissue and their rapid in vitro expansion capacity. We3
and others4 have shown that hASC produce paracrine factors that provide therapeutically beneficial effects in
multiple pathological conditions. In the context of myocardial infarction, we have shown that hASC preserve
myocardial function, inhibit apoptosis, and stimulate angiogenesis primarily through ASC-secreted factors.5
Moreover, we previously reported that pre-treatment of explanted hearts with hASC improved myocardial
functional recovery following acute I/R injury in an ex-vivo heart perfusion system.6 Our preliminary data
indicates that pre-ischemic infusion of ASC-derived paracrine factors also improves myocardial function during
recovery from cold ischemia, with significant preservation of a normal molecular pattern “fingerprint” of the
myocardial transcriptome, as defined by deep RNA sequencing. These RNASeq experiments specifically
indicate that cold ischemia leads to prominent disruption of a set of genes (Arnt/Bmal, Esrra, Per2, Per3, Cry2)
governing the circadian clock within the myocardium, which in turn prompts a coordinated increase in
transcription directing mitochondrial biogenesis; and that these disruptions are specifically counteracted by
hASC factors.
Accordingly, we propose the hypothesis that infusion of hASC-derived factors into the cardiac
circulation will ameliorate ischemia/reperfusion-induced functional deterioration of model donor hearts
ex vivo as well as of human iPS-derived cardiomyocytes in vitro, by mechanisms mediated by soluble
growth factors as well as exosomes, which limit damage to cardiomyocytes by preserving a normal
pattern of circadian gene expression and mitigating the induction of deleterious mitochondrial
biogenesis. To test this hypothesis, we will employ three specific aims:
Aim 1. Evaluate the protective effect of extracorporeal infusion of human adipose stem cell
conditioned medium (ASC-CM), fractions, on normal mouse donor heart preservation during cold
static storage.
Aim 2. Identify the specific cellular targets protected by ASC-CM as well as its exosomal and extra-
exosomal fractions, using human iPS-derived human cardiomyocytes (iCM), iPS-derived endothelial
cells (iEC) cultured individually as well as together using a three-dimensional human “myocardium-on-
a-chip” (MOC) model organ.
Aim 3. Determine the relative roles of selected molecular components of the exosomal and extra-
exosomal fractions of ASC-CM in protecting the human iEC and iCM in the MOC organ construct.

Public health relevance
Cardiac transplantation is the ultimate treatment modality for terminal heart failure, a common disease in Veterans, but its use is limited by the supply of hearts. Despite this lack, more than half of donor hearts available for transplantation are not utilized. For example, progression of ischemic cardiac damage after explantation limits use of donor hearts from geographical areas far from recipients, due to the time required for transportation. We have shown that adipose stem / stromal cells (ASC), which are readily available and cultured, markedly ameliorate ischemia and inflammation in multiple organs, including the heart; that these effects are mediated by paracrine factors and lead to major changes in circadian and mitochondrial gene transcription. We will optimize the ability of ASC-derived conditioned medium to improve cardiac preservation, and obtain novel insight into the molecular mechanisms by which this is effective, thus expanding the donor pool to the hearts obtained from donors at long distances.